NNLM Region 6 Regional Medical Library

The Hardin Library for the Health Sciences (HLHS) at the University of Iowa, the current Regional
Medical Library (RML) for the Greater Midwest Region (GMR), proposes to serve as the RML for
the newly established Region 6, consisting of: Illinois, Indiana, Iowa, Michigan, Minnesota, Ohio,
and Wisconsin. The RML has developed eight aims that will guide it through the five-year
cooperative agreement. The aims cover core focus areas that will be prioritized by the RML,
which include: governance, membership, collaboration, emergency preparedness, community-based outreach, workforce development, technology access, and evaluation. Throughout each
aim, the RML will be guided by principles of open communication, cooperation, collaboration, and
active participation. RML staff will establish bidirectional communication channels both within and
beyond NNLM. Feedback provided through internal working groups and external advisory groups
will assist in programmatic decision-making. As part of a cooperative agreement with the National
Library of Medicine (NLM), Region 6 will work under the guidance of NLM Extramural Programs
and the Office of Engagement and Training (OET) to work cooperatively to advance the mission
of NNLM. Collaboration with other RMLs, Offices, and Centers will inform activities related to
membership, outreach, and training. RML staff will seek opportunities to engage across NNLM to
build programs that can be developed nationally and rolled out regionally, or vice versa. RML staff
will also take an active roll in assessing, developing, delivering, and evaluating all national and
regional activities delivered as part of their work. The RML will be guided by a logic model, to be
developed in collaboration with the NNLM National Evaluation Center, and continuous evaluation
throughout the five-year cooperative agreement will enable data-driven decision-making
regarding programming activities.

Public health relevance
This project will support NNLM in achieving its mission to provide U.S. researchers, health professionals, public health workforce, educators, and the public with equal access to biomedical and health information resources and data. Through its eight specific aims, the Region 6 Regional Medical Library (RML) will lead community-driven approaches to promote health literacy and improve health outcomes through information, with a focus on broad populations. The work of the RML will enable individuals to make more informed decisions about their health and lead to greater health outcomes.